Preclinical efficacy of an APOE targeted antibody for Alzheimer's disease

ABSTRACT
We propose to challenge Alzheimer’s disease (AD) by modulating the interaction between Apolipoprotein E
(ApoE) and glycosaminoglycans (GAGs) using therapeutic humanized antibodies. The founders of Epoch
Biotech identified an individual that remained cognitively unimpaired until her seventies despite carrying a
Presenilin-1 (PSEN1) mutation known to cause AD-related cognitive impairment at a median age of 44 years in
the world’s largest population with autosomal dominant AD (ADAD) including over 1,200 PSEN1 mutation
carriers. Clinical and positron emission tomography (PET) imaging studies of this subject showed extremely
high amyloid but lower than expected for age tau burden and neurodegeneration. A comprehensive genetic
analysis of this individual uncovered a homozygote rare variant in ApoE3 (R136S, traditionally known as the
Christchurch variant) as the variant associated with the resistance to AD in this subject. Subsequently, our
team and others have shown that the protective effect of the Christchurch mutation is generalizable to the
broader population of patients with the ApoE4 risk variant. GAGs have been suggested to promote Aβ
aggregation and neuronal uptake of extracellular tau; and ApoE binding may be necessary for some of these
effects. The team at Schepens Eye Research Institute of Mass Eye and Ear (SERI/MEE) discovered that
ApoE3Ch displayed a dramatic reduction in GAG binding ability with heparin when compared to other ApoE
isoforms. SERI/MEE then developed an ApoE-targeted antibody (7C11) that binds to the region of ApoE
corresponding to the Christchurch mutation that can mimic the effects of ApoECh in reducing GAG binding and
the phosphorylation of tau. There is an urgent need for novel therapeutic options in the wake of the recent
news that Aduhelm has now been discontinued and the reports of limited efficacy of Leqembi for slowing
cognitive decline. Epoch Biotech was formed to commercialize the 7C11 antibody and capitalize on this
approach as an entirely novel way to treat AD. In this Phase I STTR application, Epoch Biotech and
SERI/MEEI propose to 1) characterize pharmacokinetics (PK) and biodistribution properties of humanized
7C11 and 2) test the preclinical efficacy of humanized 7C11 in a mouse model of tauopathy. Our goal is to
demonstrate the feasibility of the humanized 7C11 antibody in preventing ApoE4/GAG interactions and
reducing pTau levels, distinguishing it from current therapeutic approaches. In Phase II, we will commence
IND-enabling toxicology studies in preparation for a Phase 1 clinical trial.

Public health relevance
NARRATIVE Recently an individual was identified who had a mutation in ApoE3 known as the Christchurch mutation that protected her from mild cognitive impairment associated with autosomal dominant Alzheimer's disease until her seventies, three decades after the expected age of onset. Epoch Biotech was established to further develop, test and commercialize a humanized 7C11 antibody that binds to ApoE at the region that corresponds to the location of the Christchurch mutation that acts as a therapeutic mimetic to recapitulate the protective phenotype.